Significant high order drug interactions in the emergency department setting among older patient population

Older adults (≥65 years old) constitute about 17% of the US population but account for ~57% of the population
who use ≥3 drugs (polypharmacy). Currently, ~30million US adults use ≥3 drugs which increase their exposure
to high-order drug-drug interactions (HDDIs), i.e. drug-drug interactions involving ≥3 drugs. HDDI is a major risk
factor of serious adverse drug events (ADEs) that result in emergency department (ED) visits or hospitalization.
Older adults, compared to younger adults, are 7-times more likely to be hospitalized and 2 to 3-times more likely
to visit the ED for ADEs. However, knowledge on how to identify HDDI-ADE associations, data on the
comparative safety of different 3-drug combinations and clinical and pharmacokinetic mechanisms for HDDI-
ADE associations are all critically limited. The current project is designed to address these major gaps by
specifically: (1) applying our state-of-art data mining techniques to discover HDDIs that are associated with
higher risk of ADEs as well as those associated with lower ADE risk; (2) performing a comparative safety
assessment of 3-drug combinations involving anticoagulants, antidiabetic agents and opioids; and (3) validating
and evaluating the clinical validity and pharmacologic mechanisms of HDDI-ADE associations.
These aims will be implemented by focusing on older patients who had an ED visit based on real-world
data from health insurance claims (MarketScan and Medicare) and Electronic Health Records (EHR) data. We
will focus on gastrointestinal (GI) bleeding, hypoglycemia and opioid-induced ADEs as the primary ADEs of
interest for all three aims. These three ADEs account for 60% of all ADE-induced ED visits and are a target
priority for prevention and surveillance by the US Health and Human Services. Our preliminary data from the
MarketScan claims data (2012-2018) alone has confirmed that older adults are at higher risk of ADEs and that
the risk of these ADEs increase with the counts of concomitant drugs used by patients. We will apply our mixture
drug-count response (MDCR) and graphical models to identify the specific 3- or 4-drug combinations that have
the highest risk and those with the lowest risk of ADEs in ED settings among older adults (Aim 1). For Aim 2, we
will apply pharmacoepidemiologic study designs and casual inference approaches to assess the comparative
safety of specific high and low-risk 3-drug combinations. We will control for the potential confounding effects of
several patient-level (demographic, clinical, chronic comorbidities, drug characteristics, healthcare utilization, etc)
and provider/healthcare system-level factors to assess the causal associations between high-risk versus low-
risk 3-drug combinations. Finally, we will use a clinician expert team to evaluate the HDDI-ADE pairs and
associations identified from Aims 1 and 2 for clinical validity and utility.
The identification of high- and low-risk 3-drug combinations is vital knowledge that could guide the
development of new polypharmacy prescribing recommendations to help address the significant public health
challenge created by ADEs.

Public health relevance
PROJECT NARRATIVE Older adults (≥65 years old) are at the greatest risk of adverse drug events (ADEs) induced by anticoagulants, antidiabetic agents and opioids; these ADEs account for nearly 60% of all ADE-related emergency department visits. High-order drug-drug interactions, i.e. the concurrent use of ≥3 drugs is a major risk factor of these ADEs and is most prevalent among older adults. Knowledge on the safety of the concomitant use of ≥3 drugs is critical for preventing serious ADEs among older adults.